RADIOSENSITIZATION OF AERATED AND HYPOXIC MAMMALIAN CELLS

There is considerable evidence that the existence of hypoxic cells in human tumors may pose a problem for clinical radiotherapy. The purpose of this project is to study the effects of ionizing radiation delivered at different exposure rates with respect to cell killing, cell cycle status, and cellular redox potential of mammalian cells grown either under aerated or hypoxic conditions. A major portion of this study will be concerned with various means of modulating the cellular redox potential by using drugs that either deplete or elevate cellular glutathione (GSH). The indirect effects of GSH removal will be assessed by high performance liquid chromatography and gel electorphoresis. In addition, Nitriomidazole radiosensitizers such as SR-2508 will be studied as hypoxic sensitizers as a function of intracellular Sulphydryl concentrations. These studies should provide a better understanding of the effects of radiation to aerated and hypoxic cells. Depletion of GSH by Buthionine Sulfoximine (BSO) enhanced 2508 sensitization while GSH elevation by Oxothiazobidine (OTZ) provided protection of 2508 hypoxic sensitization. Human tumor cells lines were found to be high in cellular GSH and thus less responsive to 2508 sensitization than hamster cell lines. These data may provide explanations for the failure of Nitroimidazoles in the clinic.